DEVELOPMENT AND MAINTENANCE OF AN AGED NON-HUMAN PRIMATE TISSUE BANK

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Objective: To develop and maintain and aged nonhuman primate tissue bank. The objective of the Aged Non-human Primate Tissue Bank is to acquire, archive and distribute excess tissue from nonhuman primates that are being euthanized for research purposes at institutions around the country. Tissue will be both flash-frozen without fixation or fixed and embedded, to fit the needs of a wide-range of molecular and histochemical techniques.